The Health of Aging Parents of Adult Children with Serious Conditions

Abstract
On average, the mothers of children with serious conditions (e.g., mental illnesses, disabilities, developmental
disorders, chronic conditions) face health risks due to caregiving burdens, stress, and other factors that often
counter the many rewarding aspects of their parenting. These health implications appear to be magnified when
children reach adulthood and mothers reach late midlife and beyond. Modern medical and therapeutic
advances have increased the number of mothers in this vulnerable position, and they need support. This
project will further build the theoretically grounded empirical foundation for that support by employing an
innovative life course approach and mixed methods strategy to address this significant public health issue.
Specifically, this project extends and enriches the literature on the physical and mental health of mothers of
children with serious conditions by asking three questions. The first question (“why?”) concerns the complex
ways that the social and psychological rewards and strains of parenting children with serious conditions into
adulthood converge to shape mothers’ health in late midlife. The second question (“when?”) concerns the
potential for cumulative vs. sensitive periods of risk and resilience across years of caring for children with
serious conditions from their births into their adulthoods. The third question (“where?”) concerns the degree to
which family supports in the informal ecology and community health and human services in the formal ecology
moderate the exchange of rewards and strains to buffer health risks among late-midlife mothers of young adult
children with serious conditions. These questions will be addressed with a sequential explanatory mixed
methods strategy in which quantitative results are unpacked by qualitative insights and qualitative insights
guide subsequent quantitative analyses. This strategy integrates statistical analyses of an extant population
database with textual/grounded theory analyses of newly collected qualitative data, both focusing on mothers
in the sixth decade of life. The first involves approximately 3,100 mothers of young adult children (420 of whom
had serious conditions) in the geocoded, multilevel National Longitudinal Survey of Youth 1979. The second
involves 80 mothers of young adult children with and without serious conditions. This mixed methods sequence
is already vetted and supported by preliminary analyses of the quantitative data published in a high-impact
journal and a smaller-scale qualitative data collection funded by an NIA pilot mechanism. Conducted by an
interdisciplinary team of senior and junior scholars with complementary expertise in the study of families and
health, this project will put forward and refine a life course framework of health and wellbeing in the context of
the indefinite responsibilities of intensive parenting that can guide future research in this area and help to tailor
policies and programs aiming to serve this growing slice of the aging population. The ultimate goal is that this
foundational knowledge will then support the design of a future population study of this issue for public use.

Public health relevance
Project Narrative Employing a range of methods with extant quantitative data and newly collected qualitative data to study the link between having young adult children with serious conditions and mothers’ health in late-midlife, this project situates the health risks and benefits of aging mothers, the strains and rewards of parenting, and the needs of young adults within the overall life course, the parenting career, and ecological context while elucidating thorny social psychological processes that explain why some mothers suffer in late-midlife while others are resilient. This approach can better serve this increasing number of American women by identifying when and where to intervene and facilitating better understanding of what they need. In these ways, this theoretically grounded and policy-focused project on vulnerability and resilience in a growing population of older American women captures the spirit of Healthy People 2030 and advances many general goals of NIH.